The Environmental Determinants of Diabetes in the Young (TEDDY) Study

PROJECT SUMMARY/ABSTRACT
The Environmental Determinants of Diabetes in the Young (TEDDY) study was initiated in 2003 by six
clinical centers in the United States and Europe, including ours, to identify infectious agents, dietary factors,
or other environmental exposures that may trigger or protect against the development of islet autoimmunity
and type 1 diabetes (T1D). Additional long-term scientific goals include assessment of potential gene-
environment interactions affecting development of islet autoimmunity or T1D, gaining insight on triggering
mechanisms through detailed multi-omics analyses, and sharing collected specimens with broader scientific
community for studies of T1D pathogenesis and prevention.
A total of 424,788 newborns were screened by HLA-DR,DQ genotyping to identify children at increased risk
for T1D and 8,676 enrolled for quarterly follow-up until age 4 and semi-annually thereafter until age 15.
Now, 13 years after enrollment began, 5731 (66%) remain actively engaged in the protocol. Our Clinical
Center Finland enrolled 1834 TEDDY participants. As of 2/28/18, 194 of those have developed persistent
confirmed islet autoantibodies and 92 have been diagnosed with T1D.
Detailed analyses of biological samples from the entire cohort, along with even more comprehensive multi-
omics analyses in selected individuals, will provide a rich dataset to complement the intensive collection of
exposure data and highly efficient ascertainment of islet autoimmunity and T1D endpoints in the entire
cohort.
Specific aims of this renewal application for this multi-center, prospective cohort study for the next 5 years
are:
1. Follow the TEDDY cohort of high-risk children for development of islet autoimmunity, diabetes,
celiac disease and autoimmune thyroid disease until 15 years of age; collect biological
specimens and epidemiological data according to the study protocol.
2. Characterize genetic, epigenetic, transcriptomic, proteomic and metabolomic determinants of
islet autoimmunity and T1D in the study participants.
3. Prospectively assess infectious, dietary and other environmental exposures of study
participants as triggers of islet autoimmunity, promotors of progression to T1D, or both.
A successful study outcome will provide a dataset unprecedented in depth and breadth, to help elucidate
specific exposures and mechanisms serving in the etiology and pathogenesis of islet autoimmunity, T1D,
and closely related autoimmune diseases. The results will support the development of new strategies to
prevent, delay, or reverse the disease.

Public health relevance
Project narrative The Environmental Determinants of Diabetes in the Young (TEDDY) Study is designed to intensively study children from infancy to 15 years of age, at six clinical centers across four countries (Finland, Sweden, Germany, and the USA in Georgia/Florida, Colorado, and Washington). Infants screened at birth and identified as genetically (HLA) eligible were offered enrollment in the follow-up study, regardless of gender or ethnicity. The primary objective of this multi-center, prospective cohort study initiated in 2003 is the identification of infections agents, dietary factors, or other environmental exposures that trigger or protect against the development of islet autoimmunity and type 1diabetes (T1D).